INFLUENZA THERAPY WITH NEURAMINIDASE INHIBITOR RO 64-079

The purpose of this study is to evaluate the s, t&e of an experimental drug (RO 64-0796) in treatment of Influenza. This study will also investigate how much time it takes to relieve the symptoms of influenza and look at the effect of treatment on quality of life and cost issues.